Remote ischemic Conditioning Promotes Cerebrovascular Recovery after Intracerebral Hemorrhage

PROJECT SUMMARY
Intracerebral hemorrhage (ICH), the most common form of hemorrhagic stroke, accounts for up to 15% of all
strokes. ICH, which affects 67,000 Americans annually, induces the highest acute mortality and the worst long-
term neurological outcomes of all types of stroke. Primary ICH is caused by the rupture of small vessels damaged
by chronic hypertension or cerebral amyloid angiopathy. The resultant hematoma disrupts neural networks and
damages the vascular architecture, culminating in a loss of brain function and the need for lifelong medical
assistance. Re-establishment of a functional cerebrovascular network of small arteries and arterioles is a
prerequisite for the removal of damaged tissue and for restoration of cerebral blood flow to deliver nutrients,
trophic factors, and stem cells within the injured brain. Thus, there is a dire need for neurorestorative therapies
that provide cerebrovascular recovery after ICH. Remote ischemic conditioning (RIC), the repetitive delivery of
sub-lethal ischemia to a remote limb, demonstrated safety, versatility, and efficacy in early stage clinical trials;
however, the utility of RIC after ICH remains understudied. The objective of this proposal is to test the
overarching hypothesis that RIC induces vascular remodeling and improves long-term neurological function
via anti-inflammatory myeloid cell activation after ICH. Specific Aim 1 will test the hypothesis that myeloid
AMPKα1 mediates RIC-induced vascular repair after ICH. Specific Aim 2 will test the hypothesis that RIC
increases angiogenesis via Del-1 release after ICH. Specific Aim 3 will test the hypothesis that delayed
implementation of RIC improves chronic ICH outcomes in a sex- and age-independent manner. Expected
outcomes of the proposed research include the identification of RIC as a clinically-safe, non-invasive
intervention to promote cerebrovascular recovery after ICH. As ICH patients exhibit high permanent disability
rates that diminish quality of life, our proposed research will identify a simple therapy to harness an endogenous
pathway of neurological repair, providing an innovative and cost-effective approach to rehabilitate chronic ICH
patients.
.

Public health relevance
PROJECT NARRATIVE Intracerebral hemorrhage (ICH), the most devastating and least treatable form of stroke, is induced by a ruptured blood vessel within the brain. Unfortunately, no FDA-approved therapies currently exist to recover the extensive loss of brain function after ICH, contributing to the poor quality of life in ICH survivors. Our proposed state-of-the-art studies will determine whether remote ischemic conditioning (RIC), a simple, safe, and non- invasive therapy that involves the repetitive inflation-deflation of a blood pressure cuff on the arm, restores brain function in a pre-clinical model of ICH.